Next-Generation Cardiovascular Risk Assessments Via State-Of-The-Art Lipoprotein Characterization

Project Summary
Electronic BioSciences, Inc. (EBS) proposes to develop an entirely new analytical testing device for the
quantitative characterization of lipoprotein particles in blood. Lipoprotein particles are the primary transporters of
lipids (phospholipids, triglycerides, fatty acids, and cholesterol) in blood and other tissues. Lipoproteins are an
important indicator of cardiovascular disease, as some classes of lipoproteins are responsible for transporting
and depositing cholesterol on the walls of arteries, contributing to atherosclerosis, a harmful buildup of plaque
linked with heart attack and strokes. However, the health risks of lipoprotein particles depend on their size, so
diagnostics tests must precisely quantify the concentration, size, and other physical properties of lipoprotein
particles in order to evaluate patient risks to cardiovascular health. Current standard cholesterol tests do not
measure advanced lipoprotein particle metrics, resulting in poor diagnostic power. Advanced tests that do
characterize lipoprotein particles are performed in complex and costly central laboratories by skilled personnel,
making them unsuitable for rapid, clinical, point-of-care, and/or repeated testing. EBS’ proposed technology will
utilize a compact, inexpensive instrument to characterize all blood lipoproteins (HDL, LDL, and VLDL) with higher
speed, precision, sensitivity, and lower cost than current commercial tests. This devices’ high-precision and
accuracy will provide new measurement capabilities to researchers studying the role of lipoproteins in
cardiovascular health, and the efficacy and biological mechanisms of cholesterol-lowering drugs and other
therapies. The high speed (minutes vs. days for central lab tests) and integrated nature of our proposed testing
device will significantly reduce costs, technician training, and assay time in central laboratories, and will one day
enable point of care advanced lipoprotein testing in clinics. These capabilities will improve cardiovascular
disease diagnosis and treatment monitoring, making this lipoprotein assay the new “Gold-Standard” for
cardiovascular disease/lipoprotein testing. With the high prevalence of cardiovascular disease, even modest
improvements in diagnosis and treatment can save hundreds of thousands of lives per year worldwide.

Public health relevance
Project Narrative Current cholesterol testing methods fail to identify many cardiovascular disease (CVD) patients who need treatment to lower their cholesterol levels to reduce the risk of heart attack and stroke. This is because current cholesterol testing methods do not assay the properties of lipoprotein nanoparticles (concentration and size) that serve as better biomarkers for cardiovascular risk. Our proposed device and methodology measures advanced lipid metrics (concentration, size, zeta potential, and dielectric constant) in a compact, simple, and rapid test with lower cost and higher precision than current gold-standard methods, and will represent the new benchmark in lipid testing for CVD diagnosis, treatment, and lipidomics research.